Regulation of Osteocyte Survival by Fibroblast Growth Factor Signaling Pathways

Regulation of Osteocyte Survival by Fibroblast Growth Factor Signaling Pathways
Summary
Osteocyte death, one of the hallmarks of skeletal aging, contributes to the age-related decline in bone strength
and the increase in age-related fractures. In addition to aging, many other factors also lead to osteocyte death,
including unloading, sex hormone deficiency, glucocorticoid excess, inflammation, and osteoarthritis. Although
osteocytes function as master regulators of bone remodeling, the underlying molecular mechanisms that sustain
osteocyte viability are poorly understood. Our studies aim to fill a gap in knowledge on endogenous factors that
maintain osteocyte viability and bone quality in adult bone, as this is paramount to maintaining bone health.
This proposal examines a novel role for Fibroblast Growth Factor Receptor (FGFR) signaling in the
maintenance of osteocyte viability and skeletal homeostasis. In a recent publication, we identified a novel
requirement for FGFR signaling for osteocyte survival. We showed that conditional knockout of FGFRs in mature
osteoblasts and osteocytes led to osteocyte death in juvenile (3-week-old) mice and secondarily, increased bone
mass as these mice aged. In a preliminary follow-up study, we temporally inactivated FGFRs in osteoblasts and
osteocytes in adult (12-week-old) mice to bypass any effects on developing or actively growing bone. This also
resulted in osteocyte death after several weeks and increased bone mass after several months. These
observations form the basis of our hypothesis that in mature adult bone, FGFR signaling is required for
maintaining osteocyte viability and bone homeostasis.
Our proposed studies will address the mechanisms by which FGFR signaling maintains osteocyte viability
and skeletal homeostasis in adult mice. Using lineage tracing and anabolic loading we will determine whether
existing osteocytes vs newly formed osteocytes are sensitive to loss of FGFR signaling. In vivo analysis will
identify the primary mode of cell death and determine whether remodeling of the osteocyte lacunocanalicular
system is a cause or a consequence of loss of osteocyte viability. In vitro analysis of osteocyte cell lines will
determine if FGFR signaling pathways are required cell-autonomously for osteocyte viability.
Our preliminary data also suggests potential clinically relevant circumstances for either gain- or loss-of-
function of FGFR signaling in bone. Two FDA approved FGFR inhibitors (Erdafitinib, Pemigatinib) have a median
treatment period of 5 months for cancer. Our studies suggest that prolonged treatment with FGFR inhibitors
could affect bone homeostasis. We will thus test the effects of Erdafitinib on osteocyte viability and biomechanical
properties of bone in adult and aged mice. Finally, we will determine whether activation of FGFR signaling in
mature osteoblasts and osteocytes is protective under conditions that promote osteocyte death.
Completion of these studies will establish a role and identify mechanisms for FGFR signaling in the
maintenance of osteocyte viability and bone homeostasis in adults, they will evaluate potential adverse effects
of FGFR inhibition on bone, and will identify new genes that could be targeted to promote skeletal homeostasis.

Public health relevance
Project Narrative The osteocyte is the most abundant cell in mature bone and functions to sense mechanical stress and regulate bone homeostasis. We have found that the Fibroblast Growth Factor signaling pathway is required for osteocyte viability in adult bone. Understanding the underlying biological mechanisms connecting Fibroblast Growth Factor signaling to osteocyte viability and skeletal homeostasis will lead to the identification of new genes and pathways that could be targeted to promote osteocyte viability and maintain healthy bone.